Comparative analyses of somatic mutational processes in primates across lifespans

Project Summary Abstract
The vast diversity in lifespans among organisms provides a remarkable natural experiment in which to explore the
evolutionary innovations that have shaped the extensive variation of this phenotype. Non-human primates represent
a critical taxon for understanding the evolution of human lifespan due to their close phylogenetic proximity and broad
range of lifespans. One key hallmark of aging is genomic instability and the accumulation of somatic mutations. Only
recent improvements in the accuracy of genome sequencing have enabled the study of these mutations in aging
tissues. A subset of these mutations confer growth advantages driving carcinogenesis, however emerging evidence
also highlights their role in several other age-associated diseases and potentially aging itself. We recently
demonstrated that somatic mutation rates are inversely correlated with lifespan in mammals, consistent with a
potential causal role in aging. Furthermore, comparative genomics analyses we and others have performed across
species with diverse lifespans have determined that DNA repair genes are key players in adaptations to long life. Here,
we propose to characterize somatic mutational landscapes of aging in primate species spanning 70 million years of
evolution. These maps will be generated across 10 tissue types from a collection of marmosets, macaques, baboons,
chimpanzees and humans of diverse ages and both sexes using ultra-accurate NanoSeq mutation profiling. For a subset
of tissues we will also perform PacBio long read sequencing to assess somatic structural variants. These data will be
supplemented with NanoSeq profiling of several cell types from 17 additional primate species. Together, these maps
will allow us to ascertain how somatic mutational processes, including mutation rates and signatures, vary with age
across primate species with diverse life spans and life histories. As a result of these somatic mutations as we age many
tissues also become colonized by clonal expansions of positively selected mutant cells. To determine how these clonal
dynamics relate to species lifespan we will next perform deep targeted-NanoSeq on 250 genes, known to drive clonal
expansions in humans, across individuals of different ages from 8 of the aforementioned species. These analyses will
permit identification of the mutations driving clonal expansions, the rate at which these expansions occur during aging,
and spatial clonal dynamics across the lifespan in diverse species and tissues, informing our understanding of how they
contribute to aging. Finally, we will seek to identify the species-specific genetic determinants of these somatic
mutation phenotypes. We will perform a phylo-GWAS analysis to identify the genes associated with differences in
mutational patterns among species using both general phenotypes (e.g. lifespan, body size) as well as the molecular
mutational phenotypes identified in aims 1 and 2 (e.g. mutation rates, spectra, and clonal dynamics). These
comparative genomics approaches will allow us to link both broad primate phenotypes and quantified molecular
phenotypes to the evolutionary innovations that have impacted lifespan in the primate clade. Together these multi-
scale evolutionary comparisons will reveal factors that contribute to the diversity of life spans across primates and to
ultimately identify novel targets for interventions to extend human health span.

Public health relevance
Project Narrative The vast diversity in lifespans among organisms provides a remarkable natural experiment in which to explore the evolutionary innovations that have shaped the extensive variation of this phenotype. Non-human primates in particular represent a critical taxon for understanding the evolution of human lifespan due to their close phylogenetic proximity and broad range of lifespans. Here, we propose to characterize the somatic mutational landscape of aging across multiple tissues in primate species spanning 70 million years of evolution.